ELUCIDATION OF THE DOUBLE-BOND POSITION OF LONG-CHAIN UNSATURATED FATTY ACIDS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Linear ion-trap (LIT) MS(2) mass spectrometric approach toward locating the position of double bond(s) of unsaturated long-chain fatty acids and toward discerning among isomeric unsaturated fatty acids as dilithiated adduct ([M - H + 2Li](+)) ions are described in this report.